Metalloregulation by MerR and Fur Protein Families

DESCRIPTION (provided by applicant): A number of new principles are emerging from the study of inorganic physiology, including the idea that intracellular metals such as zinc, copper and iron are not 'trace elements' from a cellular point of view, but are routinely maintained in most cells at much higher levels (i.e., 0.6 mM). These insights, as well as the emerging literature linking metal physiology to many disease states underscore the importance of establishing the fundamental principles governing cellular metal ion regulation. Our approach to delineating these new principles involves mechanistic and structural characterization of metal receptors that switch on and off genes in a metal dependent manner. This proposal specifically focuses on how such metalloregulatory proteins control the transcriptional machinery to achieve specific types of physiological switching events. Preliminary studies reveal the first crystal structures for metal-responsive members of the MerR and Fur family proteins bound to their DNA targets, namely CueR/DNA and Zur/DNA. The new results raise a significant number of questions about how these proteins control intracellular metal ion homeostasis. The specific aims are to resolve key, unanticipated questions about the structures, functions and molecular mechanisms of these metalloregulatory proteins. The proposed experiments will employ x-ray crystallography, biophysical methods and single particle electron microscopy to understand how metal binding to the regulatory protein induces conformational changes across the promoter complex with RNA polymerase and leads to changes in gene expression. This approach will enable us to understand how metal-binding events are communicated through explicit protein and nucleic acid conformation changes into a direct effect on polymerase activity. The effects of these biophysical switching mechanisms on intracellular metal physiology will then be examined using novel single cell analytical methods with the overarching goal of establishing general principles and mechanisms that control metal ion homeostasis in normal and disease states. PUBLIC HEALTH RELEVANCE: This proposal focuses on the fundamental ways in which living cells sense and control the amount of essential nutrient metals such as copper zinc and iron. For instance, when cells need more metal, some of these sensors work by turning on metal uptake machinery, and when cells need to get rid of excess metal, other sensors work to turn on machinery that ejects metals from the cell. This control is important because an imbalance in cellular metal can lead to diseases involving infectious agents, liver disorders, diabetes and brain function.

Public health relevance
This proposal focuses on the fundamental ways in which living cells sense and control the amount of essential nutrient metals such as copper zinc and iron. For instance, when cells need more metal, some of these sensors work by turning on metal uptake machinery, and when cells need to get rid of excess metal, other sensors work to turn on machinery that ejects metals from the cell. This control is important because an imbalance in cellular metal can lead to diseases involving infectious agents, liver disorders, diabetes and brain function.